Molecular Mechanisms of Neuronal Hyperactivity in Tuberous Sclerosis Complex

Epilepsy and Autism spectrum disorder are among the most common neurological disorders that affect
children, and there is increasing evidence that dysregulation of the mechanistic target of rapamycin (mTOR) is
involved in the development of both disorders. Tuberous Sclerosis Complex (TSC) is an ideal model in which
to study the effects of abnormal mTOR signaling in the brain because dysregulation of this pathway has been
implicated in the neurological symptoms of both animal models and patients. Although the TSC-mTOR
signaling pathway has been well studied, the downstream effect of dysregulation of this pathway on neurons is
not completely understood. We have found that loss of Tsc2 in an animal model of TSC leads to down-
regulation of the critical transcription factor, Egr1, in certain sub-types of pyramidal neurons. In addition, we
have observed down-regulation of EGR1 in cortical neurons differentiated from induced pluripotent stem cells
(iPSCs) from patients with TSC, coincident with increased activity in these neurons. We hypothesize that
down-regulation of EGR1 occurs due to dysregulation of mTOR in two separate signaling complexes and
contributes to neuronal abnormalities observed in TSC, such excitatory-inhibitory imbalance. To demonstrate
the clinical relevance of this finding, we propose to confirm our observation in iPSC-derived neurons from
patients with TSC and cortical tubers from individuals with TSC. We will then examine the mechanism by which
loss of TSC2 alters EGR1 expression in iPSC-derived neurons. Finally, we will examine excitability in iPSC-
derived neurons and determine the effect of rescuing EGR1 expression on this phenotype using extracellular
recordings.
The candidate is currently a Neurogenetics fellow at Boston Children's Hospital, and this proposal builds upon
his skills in bioinformatics and extends his skillset to the use of iPSC-derived neurons to model genetic disease,
molecular and cellular techniques to study dysregulated signaling pathways, single cell sequencing, and basic
electrophysiological concepts and techniques. His proposal includes a comprehensive mentoring and didactic
plan that will allow him to successfully learn new skills and gain expertise in each of these important areas. His
primary mentor, Dr. Mustafa Sahin, is a translational neuroscientist and expert in both the clinical research and
molecular biology of TSC. In addition, the candidate has assembled a K08 advisory committee consisting of Dr.
Lee Rubin, Dr. Elizabeth Engle, and Dr. Alexander Rotenberg, who each have specific expertise in various
aspects of this proposal, such as differentiation and study of iPSC-derived neurons, single cell sequencing,
and electrophysiology. The candidate is committed to a career in translation research focusing on neurogenetic
disorders in children, and the proposed research and career development plans will enable him to successfully
transition to become an independent investigator in this field.

Public health relevance
Tuberous sclerosis complex (TSC) is a neurogenetic disorder with high rates of epilepsy and autism spectrum disorder due to dysregulation of the mechanistic target of rapamycin (mTOR) pathway. We have preliminary data suggesting that the transcription factor, EGR1, is down-regulated downstream of mTOR dysregulation in certain types of pyramidal neurons with loss of TSC2. We propose to characterize the mechanisms and consequences of this interaction in human neurons derived from induced pluripotent stem cells from patients with TSC, which will provide novel insight into the pathways underlying neurological symptoms in TSC. !